Proteomics (PRO)

The Proteomics Shared Resource (PRO-SR) was included as a Developing SR in the previous Cancer Center
Support Grant (CCSG) funding cycle. The goal of PRO-SR is to provide state-of-the-art instrumentation,
technical expertise, and advanced informatics support for the application of mass spectrometry-based
proteomics to wide-ranging queries including understanding the role of proteins in cancer development and
progression, to identify cancer biomarkers and therapeutic targets. PRO-SR leadership and personnel, with
their broad and deep knowledge of biology, informatics, and proteomics, educate and guide Rogel Cancer
Center members to implement advanced proteomic technologies which have proven invaluable.